Mechanisms of immune-mediated neuronal damage in a mouse model of optic neuritis

Proposal Summary/Abstract
One of the most common yet understudied symptoms of multiple sclerosis (MS) is optic neuritis (ON). ON
consists of the autoimmune demyelinating lesions typical of MS occurring within the optic nerve causing
inflammation and neuronal damage. This can lead to pain with eye movement and vision loss, and while
current therapies targeting the immune system can achieve remission, relapses are common. Most work has
been focused on the immune system leaving the neuronal components of ON pathogenesis unknown. This
project aims to elucidate mechanisms underlying immune-mediated neuronal damage during ON. Previous
work in the Dittel lab discovered that cultured mouse embryonic neurons experienced microtubule
destabilization when treated with lytic granules from activated immune cells with cytolytic potential, such as
those known to contribute to MS. Microtubule destabilization has been implicated in other neurodegenerative
diseases and is often accompanied by tau hyperphosphorylation. Tau is a microtubule stabilizing protein that
becomes dysfunctional once hyperphosphorylated. In the mouse model of MS, experimental autoimmune
encephalomyelitis (EAE), tau hyperphosphorylation has been observed, further suggesting microtubule
destabilization as a key mechanism in immune-mediated neuronal damage. Although ON affects a different
population of neurons compared to EAE, we hypothesize the mechanisms of damage are conserved across
neuronal populations. This proposal will test that hypothesis and elucidate the contribution of microtubule
destabilization on disease development and severity using pharmacologic agents known to alter microtubule
structure and stability. Understanding the role of microtubules will provide insight into the downstream effects
and functional consequences of the damage, but the cell surface receptor must also be identified to provide a
direct link to the immune response. Our work focuses on G-protein coupled receptors that can be activated by
components released in lytic granules by activated immune cells. We propose utilizing a combination of
pharmacologic inhibition and knock-out animal models to isolate the contribution of a target receptor. All
experiments will be assessed using a unique blend of histological and non-invasive imaging techniques, such
as optical coherence tomography. This proposal will uncover mechanisms critical to ON development and
severity, demonstrate evidence for conserved neuronal signaling machinery activated during immune-mediated
damage, and examine the therapeutic potential of hypothesized targets using FDA approved drugs.

Public health relevance
Project Narrative This project will utilize cutting-edge techniques to test signaling mechanisms hypothesized to drive development of optic neuritis through immune-mediated neuronal damage. While most treatments for optic neuritis are aimed at mitigating the immune response, this proposal will provide novel insight into potential therapeutic targets within the neuronal response.